Automated, optimized, intelligent data collection for cryo-EM

PROJECT SUMMARY
Cryo-electron microscopy (cryo-EM) has become a transformative technique for determining high-resolution
structures of macromolecules, providing insights into complex biological systems that drive our understanding of
disease and inform drug design. Despite its success, the level of quality control and automated guidance of high-
throughput necessary for the widespread adoption of structural studies requires further improvements. This grant
aims to continue the development of Magellon, a next-generation software suite that advances cryo-EM data
collection through enhanced automation, real-time analysis, and improved sample preparation workflows. We
have established a foundational codebase that will be used to develop advanced web-based tools to enable
users to monitor, visualize, and analyze cryo-EM data in real time. Initial development of Magellon will focus
primarily on single-particle workflows and will subsequently integrate tomography workflows. Emphasis on the
ability to accommodate customizable plugins for various data acquisition functions, such as particle picking,
focusing, and CTF estimation, will be at the heart of development. This modular approach allows external
developers to add tools directly to Magellon, creating an ecosystem where the community can contribute and
test new algorithms without altering core software. These capabilities are especially valuable at regional and
national cryo-EM centers, where Magellon’s web-based accessibility and customizable plugins will expand utility
across institutions and improve high-quality data acquisition for diverse research needs. However, since the goal
of this project is to enable hands-free, fully automated data acquisition, we will leverage our modular framework
to integrate new algorithms within Magellon for fully automated data acquisition. To this end, we will largely focus
on a standalone platform, CryoEM CoPilot, that will serve as an intelligent data collection assistant. This assistant
will use machine learning to dynamically optimize microscope parameters and grid navigation based on ongoing
data quality. By leveraging machine learning for real-time decision-making, CryoEM CoPilot will adapt to each
sample’s unique features, focusing on high-quality regions and minimizing time spent on suboptimal areas. This
approach represents a significant advance over traditional static acquisition strategies, enabling more efficient
and precise data collection that reduces the need for expert intervention. Lastly, we will also develop tools for
screening and optimizing buffer conditions to identify conditions that yield the most stable samples for cryo-EM.
By analyzing protein-protein interactions in various buffer environments, this method will help identify conditions
that reduce aggregation and prevent preferred orientation, common issues that can compromise cryo-EM data
quality. Together, these aims will establish Magellon as a versatile, modular, and highly extensible platform for
cryo-EM, designed to serve as a central resource for the cryo-EM community. By enhancing automation, data
feedback, and sample quality, Magellon will make cryo-EM more accessible, reliable, and efficient, enabling
scientists to fully exploit the potential of cryo-EM in biomedical research.

Public health relevance
NARRATIVE The development of therapeutics for diseases, which includes vaccines to fight viruses such as COVID-19, is substantially aided by directly visualizing the viruses or cellular components responsible for causing disease. The NIH has established numerous National Centers that contain the most powerful microscopes on the planet, enabling biologists across the country to look at these tiny disease-causing components. We will design and build a series of cutting-edge computer programs to help biologists take better pictures, so that we are able to more quickly make biomedically important discoveries.